Cancer Control Program

Cancer Control Program: Summary/Abstract
The goal of the HDFCCC Cancer Control (CC) Program is to use a multi-disciplinary team approach to
understand and intervene on the structural and social determinants of cancer, leading to improved cancer
health outcomes and equity. This goal will be achieved by using intra- and inter-programmatic team science to
advance understanding of these multilevel determinants and to develop, translate, and implement effective
behavioral, clinical, and policy interventions that will reduce the burden of cancer in the catchment area and
achieve equity in cancer health outcomes.
The CC Program follows a “cells-to-society” approach interrogate the biological mechanisms underlying
structural and social determinants of cancer and translate these into interventions. The CC Program has the
capacity to integrate discovery, intervention, and delivery research. To do so, the program (1) identifies the
causes of outcomes across the cancer continuum, with attention to diverse populations, including structural,
social, policy, industrial, and environmental influences on tobacco use, physical activity, other risk factors,
cancer screening, and care; (2) develops, implements, and evaluates evidence-based interventions to reduce
the cancer burden and improve cancer health equity in the HDFCCC catchment area; and (3) translates
knowledge into effective policies and programs to achieve equity in outcomes across the cancer continuum.